IMUNOMODULATORY EFFECTS OF ANSAID AND MRI SCANS IN RHEUMATOID ARTHRITIS

The purpose of this study is to evaluate the effects of the nonsteroidal antiinflammatory agent Ansaid (flurbiprofen) on immunological and radiographic features of rheumatoid arthritis.